Cherokee Nation Native American Research Centers for Health (NARCH) 11

Abstract
Major health disparities continue to impact tribal nations, yet a serious shortage of scientists conducting
American Indian (AI) health disparities research persists. For several years, Cherokee Nation, the University of
Oklahoma (OU) system, and the Oklahoma Medical Research Foundation (OMRF) have partnered to address
this issue by building tribal research capacity through the Native American Research Centers for Health
(NARCH) mechanism. In this cycle of NARCH funding, the partnership among Cherokee Nation, OU, and
OMRF continues and, importantly for student career enhancement, expands to include the Oklahoma State
University (OSU) system as a key partner for student career enhancement activities. The overall mission of
Cherokee NARCH is to develop durable research capacity within the context of an American Indian (AI) tribal
nation to address health disparities. To achieve this goal, the five Specific Aims of Cherokee NARCH are:
1. to strengthen administrative infrastructure, including a Leadership Team (LT) and a Tribal-Campus
Advisory Committee (TCAC), that ensures integration of career enhancement, capacity building, and
research activities;
2. to educate the next generation of researchers to engage meaningfully with Cherokee Nation in the
context of tribal research, focusing on undergraduate, graduate and health professions students;
3. to build tribal capacity by developing a set of research codes to govern the conduct of genomic and other
biomedical research predicated on the concept of tribal data sovereignty;
4. to conduct innovative research and pilot research capable of seeding future research projects
performed by researchers seeking to work within the Cherokee Nation setting; and
5. to evaluate activities of the partnership, including monitoring progress of student career enhancement,
capacity building, and research/pilot research projects, and evaluation of the overall Cherokee NARCH
program.
Cherokee NARCH provides a crucial opportunity to solidify the foundation for tribal capacity in health
disparities research. The addition of OSU strengthens Cherokee NARCH by its remarkable success in the
education of AI students in scientific and health professions fields, including the advent of the first tribally
affiliated medical school in the US. Cherokee NARCH therefore provides an unprecedented environment in
which a tribe, two research-intensive universities with large AI student populations (OU and OSU), and a
biomedical research foundation (OMRF) will work synergistically to reduce the unacceptable disparities in
health that continue to affect AI people.
/

Public health relevance
Narrative American Indian communities suffer disproportionately from a range of health disparities. Cherokee NARCH will expand authentic tribal capacity to address these disparities through a coordinated program of student career enhancement, capacity building, and research/pilot research activities directly providing research experiences for students in the Cherokee Nation setting. /